BIOACTIVITY ASSAY DEVELOPMENT CONSULTANT SUPPORT SERVICES

Bioactivity Assay consultants may be required to evaluate bioactivity assays and
recommend strategies and experiments to optimize and/or validate the assays for use in a
medicinal chemistry campaign. Bioactivity Assay consultants may be asked to assist in
the establishment of milestones related to assay optimization or validation. The NIH may
seek guidance from consultants on the design and interpretation of commonly used in
vitro assays, such as biochemical and cell-based assays. Specific consulting
responsibilities will depend on the expertise of the individual consultant and the needs of
April 15, 2016 Page 3 of 7
individual projects. Assay-related consultation services may be required on an ad hoc
basis or on LDTs.
The role of the Bioactivity Assay consultant may include but is not limited to the
following responsibilities and tasks:
• In partnership with other consultants, contractors, and NIH staff, advise,
strategically plan, and manage programs to facilitate lead optimization, INDenabling studies, and clinical studies.
• Serve as a resource to LDT for assay requirements and logistics to conduct drug
development activities for small molecule compounds from the preclinical stage
through to the initial clinical stage
• Serve as the assay expert in order to identify potential developmental challenges
and suggest strategies to address these challenges.
• Collaborate o

Public health relevance
Subject matter expert support for developing therapies for neurological disorders